Evaluation of tafenoquine for prophylaxis of babesiosis caused by Babesia microti

PROJECT SUMMARY/ABSTRACT
Human babesiosis caused by the hemoparasite Babesia microti is an emerging tick-borne disease in the
United States. Symptoms include fever, chills, sweats, headache, myalgia and anorexia. In young and healthy
individuals, symptoms tend to be few and mild. In individuals >50 years of age and in immunocompromised
patients, symptoms can be severe and hospital admission required. Despite medical care, complications such
as severe anemia, adult respiratory distress syndrome and renal insufficiency or failure can develop. Death is
the outcome in 2-3% of hospitalized cases. Prophylaxis is limited to endemic area avoidance and tick exposure
reduction. These measures have been ineffective in curtailing the emergence of babesiosis. No vaccine is
available and no chemoprophylaxis has been tested for babesiosis. Tafenoquine is approved for pre-exposure
prophylaxis of malaria and radical cure of Plasmodium vivax infection. The prophylactic regimen consists of a
loading dose taken for three consecutive days followed by a weekly maintenance dose until one week after
travel. The therapeutic regimen is a single dose taken along with chloroquine. Tafenoquine has never been
tested as prophylaxis for babesiosis. Pre-clinical studies indicate that i) prompt resolution of B. microti infection
is achieved by single dose tafenoquine but ii) radical cure is attained only if tafenoquine is administered over
several consecutive days. In a recent case report, we were the first to document the therapeutic benefit of
tafenoquine in an elderly immunocompromised patient who suffered from relapsing babesiosis in the context of
broad antimicrobial resistance. Cure was achieved following initiation of tafenoquine. We hypothesize that
tafenoquine can be used for the prophylaxis of babesiosis, including when the host immune response is
weakened by advanced age or severe immune suppression. In Aim #1, we will use the DBA/2J mouse strain to
model the severe babesiosis of old age. We will initiate our studies by infecting young DBA/2J mice and, in
doing so, identify regimens that offer a prospect of conferring prophylaxis in old age. Briefly, we will administer
tafenoquine for three consecutive days during the “window period”, starting on day 3 post-infection. We will
monitor the course of parasitemia from its onset (day 7) until day 35 post-infection. We will ascertain whether
radical cure is achieved by adoptive transfer of blood to rag-deficient mice. We identify the protective regimen
that uses the lowest daily dose and test whether this regimen confers prophylaxis to old DBA/2J mice. We will
detect tafenoquine in plasma by use of LC/MS/MS and identify the maximal concentration and the overall drug
exposure required for prophylaxis in young and old DBA/2J mice. In Aim #2, we will use young rag-deficient
BALB/c mice to model severe immune suppression. We will test whether prophylaxis of rag-deficient mice
requires a daily dose higher than those used for prophylaxis of young and old DBA/2J mice. If successful, the
work will lay the ground for a clinical trial that will test tafenoquine for post-exposure prophylaxis of babesiosis.

Public health relevance
PROJECT NARRATIVE Human babesiosis caused by the hemoparasite Babesia microti is an emerging infectious disease in the United States. Current prophylactic measures aim at reducing exposure to the Ixodes scapularis tick, the vector that maintains Babesia microti in its enzootic cycle and incidentally feeds on humans. Using mouse strains that model severe Babesia microti infection caused by old age or severe immune suppression, the proposed research will seek to identify tafenoquine regimens that confer post-exposure prophylaxis.